Cell-free hemoglobin-oxidized LDL-LOX-1 axis and microvascular hyperpermeability during sepsis

Sepsis, a dysregulated host response to infection with high morbidity and mortality, is characterized by a
systemic inflammatory response and widespread vascular hyperpermeability leading to edema, organ
dysfunction, and death. Lung vascular hyperpermeability in sepsis contributes to acute respiratory distress
syndrome (ARDS), with no specific prevention or treatment strategies. Disruption of the microvascular
endothelial cell (MVEC) barrier is a critical pathological feature of sepsis-induced lung injury driven by
circulating inflammatory mediators, oxidants, and proteolytic enzymes. Our group has shown that plasma
cell-free hemoglobin (CFH), released during sepsis due to red blood cell fragility, is a mechanistic driver of
acute lung injury through induction of lung MVEC hyperpermeability. However, the cellular and molecular
mechanisms are unknown. One potential mechanism by which CFH may disrupt the MVEC barrier is
through its known ability to oxidize low-density lipoprotein (oxLDL). OxLDL binds and signals through its
major endothelial receptor lectin-like oxidized LDL receptor 1 (LOX-1) to cause endothelial dysfunction.
LOX-1 activation has been implicated in cardiovascular diseases such as atherosclerosis but its
involvement in MVEC hyperpermeability during sepsis is unknown. Our preliminary data from patients with
sepsis show that circulating CFH and oxLDL are tightly correlated with each other, MVEC injury markers,
and mortality. However, little is known regarding LOX-1 receptor signaling leading to hyperpermeability,
especially in the context of sepsis-induced injury to the lung microvasculature. This proposal aims to test
the central hypothesis that MVEC hyperpermeability and lung injury during sepsis are mediated through
oxidation of LDL by CFH to induce LOX-1 receptor signaling and ectodomain shedding.

Public health relevance
My career and long-term research goals are to establish an independent academic research program to identify novel signaling mechanisms regulating microvascular endothelial hyperpermeability during sepsis that can be targeted therapeutically for treatment of sepsis-induced organ dysfunction. The proposed research and training in this application will provide a foundation for my career as an independent academic investigator and position me well to achieve my goal of becoming a leader in mechanistic and